Systemic sclerosis (SSc) vasculopathy: Improved clinical monitoring and treatment

Systemic sclerosis (SSc; scleroderma) is a complex autoimmune disease without a cure or an effective
therapy for the many devastating aspects of disease. Mouse models do not recapitulate all features of SSc,
mandating human studies for understanding this complex pathogenesis. The median survival is ~11 years after
SSc diagnosis and the estimated national hospital costs related to SSc exceed 275 million yearly. SSc affects 250
per 1 million people in the US, with a ~3-4 time greater prevalence among Veteran’s Health Administration
patients. The pathogenesis of SSc is characterized by immunological abnormalities, vascular changes, notably in
the microvasculature, and fibrosis, yet both the cause and effect of these mechanisms within the gastrointestinal
tract (GIT), which is the most common extra-cutaneous organ system damaged in SSc, is unknown.
Our previous work supported by I01 CX002111-01 “Systemic sclerosis (SSc) vasculopathy: Improved
clinical monitoring and treatment” discovered that that both large artery (i.e., brachial artery), as well as
microvascular (i.e., arterioles and capillaries) endothelial dysfunction is a critical feature of SSc. A dysfunctional
endothelium leads to increased vascular permeability, greater tissue immune cell infiltration, blunted angiogenic
capacity and impaired vascular reactivity and tissue blood flow. While we showed that acutely we could improve
this vascular dysfunction, clinical interventions are limited by trial design issues and are greatly improved by
models that specifically study the mechanism of disease. We identified a novel method for quantifying
microvascular change in the oral cavity (sublingual videomicroscopy) that correlates to GIT symptoms in SSc.
This sublingual videomicroscope measures the glycocalyx, which maintains homeostasis of the vasculature,
including controlling vascular permeability and microvascular tone, preventing microvascular thrombosis, and
regulating leukocyte adhesion.
In the first specific aim of our proposed study, we will perform a natural history study of the glycocalyx,
its relation to GIT patient reported outcomes (PRO) and end-stage vasculopathy features, including digital ulcers
(DU), pulmonary hypertension (PH), scleroderma renal crisis (SRC), calcinosis, and telangiectases. In the second
specific aim of the proposed study, we will develop a novel model to further study these end-stage vasculopathy
features (DU, PH, SRC, calcinosis, telangiectases, and severe GIT symptoms) in Veterans with SSc. We will
generate endothelial cells (EC) from inducible pluripotential stem cells (iPSC) created from their blood and age-
frequency and sex matched healthy controls. The main research objective of this project is to build upon our
current clinical research program for our Veterans with SSc that has identified important in vivo aspects of SSc
vasculopathy and its relation to PRO. The over-arching goal of this project renewal is to define SSc-GIT
vasculopathy through serial microvascular measurements in the vasculature of the mouth and correlate these to
symptoms, end-stage vasculopathy clinical features, and glycocalyx characterization. We will then investigate the
etiology of end-stage vascular complications through the establishment of a SSc-iPSC-EC model that can be
tested for permeability, healing, and leukocyte rolling. Thus, this proposal will clarify SSc vasculopathy
pathogenesis through serial sublingual microvascular microscopy, GIT PRO, markers of glycocalyx dysfunction,
and testing of SSc-iPSC-EC generated from peripheral blood. This vasculopathy characterization can potentially
allow us to identify targeted clinical assessments, develop effective management plans, and apply therapeutic
screens for this devastating disease that effects our Veterans quality of life, and for which we currently have a
very limited understanding of pathogenesis. Importantly, the novel iPSC model developed in this project has the
potential to be used in other rare diseases characterized by vascular dysfunction that effect our Veterans.

Public health relevance
Systemic sclerosis (SSc) has a ~4-time greater prevalence among Veteran’s Health Administration patients. Severe end-stage vascular manifestations of SSc, such as pulmonary hypertension, digital ulcers, scleroderma renal crisis, calcinosis, telangiectases, and malnutrition due to gastrointestinal tract involvement represent a continuum of damage that results of increased endothelial cell permeability and dysregulated vascular tone, which ultimately results in fibrosis. Although SSc is heterogeneous in the extent of organ involvement and prognosis, it is accepted that all SSc cases have a progressive and usually devastating course. Current SSc animal models are insufficient for studying this complex pathogenesis; however, inducible pluripotential stem cells offer a novel method to build upon our prior work that supports sublingual microvascular measures of the glycocalyx can clarify the pathogenesis of end-stage symptomatic vasculopathy.